Emulating hypothetical target trials to establish the comparative effectiveness of biologics in asthma

PROJECT SUMMARY/ABSTRACT
Asthma is a leading cause of morbidity in the US and worldwide, affecting almost 10% of the US
population. Individuals with severe asthma, who are uncontrolled on conventional therapy,
account for a disproportionate share of asthma-related morbidity and mortality. For these
patients, the advent of multiple monoclonal antibodies “biologics” has provided additional
therapeutic options to improve outcomes in this potentially fatal disease. While these biologics
have helped to improved outcomes in many patients with asthma, there is considerable
uncertainty on the optimal choice of biologic in patients who meet criteria for two or more
biologics, a common occurrence. There are no head-to-head trials of these therapies and
results of indirect treatment comparisons have been limited or conflicting. Moreover, indirect
comparisons are fraught with multiple limitations, including that the populations recruited into
different trials for the therapies being compared may differ in ways which may influence the
outcome(s) of interest. Consequently, current asthma guidelines have limited evidence-based
guidance on how to approach biologic initiation in patients who are eligible for multiple biologics.
To optimize the value of these expensive biologics, data on their comparative effectiveness are
solely needed. In the absence of randomized trials, observational data can be used to generate
evidence on the comparative effectiveness of these biologics using ‘real-world’ data. However,
to mitigate biases in non-experimental research and to ensure sound conclusions are drawn
from the data, we need to leverage subject matter expertise with advanced and innovative
causal inference and pharmacoepidemiology techniques. This proposal leverages the PI and
study team’s clinical expertise in asthma and monoclonal antibody research with expertise in
causal inference and epidemiologic study design to emulate hypothetical randomized and
adaptive trials in answering questions on the comparative effectiveness of the respiratory
biologics approved for asthma. We will compare the monoclonal antibodies in pairwise
comparisons and simultaneously. In addition, we will identify the dynamic treatment-switching
strategy which maximizes outcomes in patients with severe asthma. This research is poised to
fill important gaps in the evidence-base of respiratory biologics in asthma potentially leading to
improvements in the care of individuals with severe asthma. Additionally, it will provide a
framework that can be applied to other therapies and conditions.

Public health relevance
PROJECT NARRATIVE The advent of multiple monoclonal antibodies for the treatment of asthma has led to the increase in therapeutic options but in the absence of head-to-head trials, the optimal biologic for individuals eligible for two or more of these therapies is often unknown. This proposal seeks to use longitudinal health care data to emulate randomized and adaptive trials of respiratory biologics thereby providing an evidence base for the use of these biologics in asthma. Additionally, the novel methodological framework using ‘real-world’ utilization and effectiveness to emulate randomized and pragmatic trials will be a major advance on current non- experimental comparative effectiveness studies and can be applied to other therapies and conditions.